Unconditional cash income and involvement with child protective services: Evidence from the expanded child tax credit

PROJECT SUMMARY/ABSTRACT
The social costs of child abuse and neglect are staggering, with the lifetime economic burden of one year
of child protective services (CPS) cases reaching an estimated $592 billion. It is well-established that low-
income and poverty are strongly correlated with CPS involvement. Studies have shown that increasing
income is associated lower rates of CPS involvement, with some evidence that this relationship is causal
in nature. Yet, this research is limited in two critical aspects. First, all the causal studies to date evaluate
the effect of additional income received from work-conditioned income via tax credits, meaning that the
additional income is conditional upon parental employment. Economic theory suggests that income
received via unconditional tax credits should lead to lower rates of CPS involvement because it can
increase parental investments without decreasing parental time with children and because the most
disadvantaged under- and unemployed parents are categorically excluded from existing work-conditioned
credits. Second, as minoritized families are disproportionately both involved with CPS and un- or under-
employed, a key question is whether the effects of unconditional cash transfers reduce well known racial
disparities in CPS involvement. Our team’s recent microsimulation study found that an unconditional cash
transfer would nearly eliminate racial disproportionality in CPS involvement. Yet, the average and race-
specific causal effects of unconditional cash transfers on CPS involvement and the mechanisms
underlying this relation remain unknown. That is the gap our proposed research aims to fill. To answer this
question, we propose to evaluate the effects of the unconditional income received by families as part of
the 2021 American Rescue Plan Act expanded child tax credit (CTC), the nation’s first monthly child
allowance-type unconditional cash transfer. We innovate by using population-level linked administrative
data that will enable us to longitudinally observe CPS involvement and other aspects of objective child
health and safety, including relatively rare outcomes, and many parent- and child-level mechanisms that
plausibly underlie this relationship. Aim 1 evaluates the effect of an unconditional cash transfer via the
expanded CTC on CPS involvement and other objective measures of safety and wellbeing among infants.
Aim 2 considers the CTC’s effects on children ages 1 to 17 and Aim 3 tests for racial/ethnic differences. All
three aims include an exploratory analysis of mechanisms. This study will provide the first rigorous
evidence for policymakers and practitioners on the value of unconditional cash income to reduce CPS
involvement and reduce racial disparities therein. Our results will shed light on the nuances in poverty
policy design that are imperative for equitable transmission of health and safety for children, providing
novel insight into the ways that economic supports do or do not reduce racial disparities in CPS
involvement.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it will identify how unconditional cash income policies can be used for the primary prevention of child abuse and neglect and to reduce racial disparities in child protective services involvement. This research innovatively considers both objective and subjective measures of child wellbeing and undertakes an exploratory analysis of mechanisms to advance knowledge on how the additional income affects health equity, in line with the NICHD’s mission.